Regulation of synaptic activity by mRNA methylation

PROJECT SUMMARY
Neurotransmitter release at synaptic terminals is tightly controlled, and its dysregulation has profound
consequences for neural circuit activity and disease. Here, we propose to examine the in vivo impact of N6-
methyladenosine (m6A), the most common internal modification of mRNA, on synaptic biology. Our ongoing
efforts uncover how Drosophila mutants of m6A factors alter normal synaptic function at the neuromuscular
junction (NMJ) and suggest new mechanisms for m6A regulation. We will build on this knowledge to dissect
how m6A controls the ability of neurons to adjust their set point for neurotransmitter release at the synapse.
This proposal will (1) establish critical roles for the epitranscriptome in normal synaptic function, (2) provide
comprehensive genomic data on m6A targets and the regulatory impacts of these modifications, and (3) define
new regulatory mechanisms by which m6A operates and intersects with other neuronal regulatory pathways.
This work will provide conceptual advances to our knowledge of the regulation of neuronal activity under
physiological conditions and in disease.

Public health relevance
PROJECT NARRATIVE N6-methyladenosine (m6A) represents the most abundant internal modification of mRNA, and while we now have a reasonable understanding of the biochemical machinery that places this epitranscriptomic mark, we are still in the infancy of understanding its biological importance in vivo. Recent efforts point to the nervous system as being especially sensitive to m6A-mediated gene regulation. This project will integrate powerful genetic, genomic, biochemical, and electrophysiological tools available in the Drosophila system to determine how m6A regulates synaptic activity at the neuromuscular junction, and dissect multiple molecular mechanisms by which m6A imparts regulatory impacts in the nervous system.